Deciphering the role of cancer pain-associated neuronal activity in driving malignancies

PROJECT SUMMARY
Recent paradigm-shifting discoveries demonstrated that neurons are critical drivers of malignancies (cancer),
leading to clinical trials to test neuromodulatory drugs in cancer patients. Many types of cancer are associated
with severe pain which indicates sensory neuron hyperactivity, raising the intriguing possibility that cancer pain-
associated sensory neuron activity accelerates cancer progression. Our long-term objective is to understand
the role of neuronal activity in cancer pathophysiology and identify therapeutic targets to improve
cancer patient survival and quality of life. Leveraging preclinical models of malignant peripheral nerve sheath
tumor (MPNST), where the neoplasm develops within peripheral nerves, our preliminary data reveal that MPNST
cells induce sensory neuron hyperactivity and pain, and that sensory neuron activity accelerates tumor growth.
Based on these findings, our central hypothesis is that a feedforward mechanism exists between cancer
pain-associated sensory neuron hyperactivity and MPNST growth. We will address the hypothesis by
uncovering how MPNST cells activate sensory neurons to promote cancer pain via fibroblasts (Aim 1) and
determining the mechanisms underlying pain-associated sensory neuron activity-mediated tumor progression in
a neuronal subtype-dependent manner (Aim 2). To achieve these aims, we have assembled a multi-disciplinary
team consisting of cancer neuroscientists (Yuan Pan, PhD and Xiaofan Guo, MD-PhD), pain researchers (Peter
Grace, PhD and Andrew Shepherd, PhD), an MPNST physician-scientist (Angela Hirbe, MD-PhD), a pathologist
(John Chrisinger, MD), a bioinformatician (Rajasekaran Mahalingam, PhD), biostatisticians (Chongliang Luo,
PhD and Roland Bassett, PhD), and a data management and sharing expert (Robert Allaway, PhD). Together,
we will leverage genetically engineered mice, mouse and human MPNST cells, human MPNST tumor
specimens, and neuroscience approaches to test the hypothesis. Successful completion of these studies will
uncover the mechanisms under which cancer pain-associated neuronal activity interacts with MPNST cells to
drive malignancy. Findings from this study will open a new avenue for predicting prognosis and improving the
survivorship and quality of life of patients with these deadly tumors.

Public health relevance
PROJECT NARRATIVE This proposed project provides proof-of-concept studies that there exists a feedforward cycle between cancer pain-associated sensory neuron hyperactivity and cancer progression in peripheral nerve sheath tumors. Findings from this study will uncover the mechanisms under which pain-associated sensory neuron activity interacts with cancer cells to accelerate tumor progression, and will open new avenues for potential prediction and treatment strategies for this deadly cancer. Last, our findings will provide valuable insight into the emerging multi-disciplinary field of cancer neuroscience.